Dayton Clinical Oncology Program

Dayton Clinical Oncology Program (Dayton NCORP): Project Summary/Abstract
The Dayton Clinical Oncology Program, hereafter referred to as “Dayton NCORP”, was incorporated in
the State of Ohio in 1983 as a non-profit 501c3 corporation, and one of the original NCI Community
Clinical Oncology Programs (CCOP). At that time, a consortium agreement was established between
Dayton NCORP, the Dayton area adult hospitals, and Wright State University (WSU). A governing
board was established, and corporate bylaws were developed.
Kettering Medical Center was the original grantee organization until 2001, when Dayton NCORP
subcontracted with WSU for human resources, technical support, and financial oversight. Dayton
NCORP contracts with a local accounting firm to conduct an annual external A-133 financial audit. In
2014, Dayton Clinical Oncology Program, was successfully awarded an NCI Community Oncology
Research Program (NCORP) Community Site five-year grant.
Currently, the Dayton NCORP Board of Directors is led by Principal Investigator Howard M. Gross,
M.D. as Chairperson, Roger Wood, M.D., Associate Principal Investigator and Vice Chairperson of the
Board, and Mary Ontko, BSN, RN,CCRP, President of the Board and Chief Executive Officer. Other
directors represent consortium hospital-members. The Board meets semi-annually to review budget
reports and program activities.
Our research team is composed of 42 physicians and 3 fellows specializing in medical, surgical, and
radiation oncology; 5 nurse practitioners; 13 hospital- and office-based oncology research nurses
funded by our member hospitals; and 10 office staff supported by an NCI grant. Over the past 40 years
as part of the NCI network, we have built a strong infrastructure supported by long-standing employees
who provide comprehensive administrative, regulatory, quality assurance, and research project support
to our consortium members. Our research coordinators conduct a secondary eligibility review before
any patient enrollment and are responsible for submitting data to the research bases for all enrolled
patients. Additionally, we offer pharmacy and specimen support through our on-site pharmacy
technician.
Dayton NCORP is currently seeking continued funding through the one-year grant extension for August
1, 2025, through July 31, 2026. Continued funding will allow the consortium to continue the Dayton
NCORP mission to reduce cancer incidence and mortality through improved treatment and prevention
by offering national state-of-the-art cancer research to the local communities.
Page 14
Project Summary/Abstract

Public health relevance
Dayton Clinical Oncology Program (Dayton NCORP) Project Narrative: Since 1982, the Dayton Clinical Oncology Program has been fundamental in increasing access to NCI clinical trials to patients in communities throughout Ohio and Indiana. Patients can participate in treatment, cancer control and prevention studies, along with Cancer Care Delivery Research (CCDR) without leaving their communities. This provides significant contributions to further development in cancer care.